Molecular mechanisms of lipid transfer by bridge-like lipid transfer proteins

Summary
Cells and cellular organelles are surrounded by membranes that are constantly undergoing lipid modification
due to processes like cell growth, organelle biogenesis, exocytosis, autophagy, phagocytosis, and temperature
adaptation. The recently discovered, evolutionarily conserved superfamily of bridge-like lipid transfer proteins
(BLTPs) are essential for all these processes due to their role in lipid transport. BLTPs localize to membrane
contact sites, where they fold into hydrophobic tunnels that are proposed to function like “lipid superhighways”
that mediate the bulk transfer of lipids from donor to acceptor membranes. Despite the fundamental importance
of BLTPs in cellular function and organismal survival, little is known about how they function, largely due to
challenges associated with producing of BLTPs in heterologous cell lines. The overarching goal of my research
is to overcome these challenges and answer fundamental questions surrounding BLTP function, including (i)
how do BLTPs transfer lipids from the donor to the acceptor membrane, (ii) what is the role of BLTP-mediated
lipid transfer in cellular physiology, and (iii) how does BLTP dysfunction lead to disease. As a foundation for this
work, we have recently elucidated the structure of a native BLTP complex from C. elegans, revealing unexpected
structural and functional features that provide mechanistic insight into the process of lipid transfer. Over the next
five years, our research will focus on understanding the molecular mechanisms of lipid transport by BLTP1 and
BLTP2, two of the five members of the BLTP superfamily, using single particle cryo-electron microscopy in
combination with complementary genetic, biochemical, and computational methods. We will address key
outstanding questions in the field of BTLP-mediated lipid transfer, including the selectivity for specific membrane
lipids, the regulation of transport, and the mechanisms of lipid extraction and delivery. Moreover, as mutations in
BLTPs are implicated in multiple neurological disorders, we will harness the C. elegans and D. melanogaster
model systems to investigate the molecular underpinnings of BLTP dysfunction in these diseases. The
knowledge gained from this research will provide a comprehensive understanding of the relationships between
BLTP structure and function that will illuminate the mechanisms of lipid transfer at membrane contact sites. In
addition, the methods for native protein isolation and characterization that we develop over the course of this
work can also be applied to other challenging protein complexes, enabling the study of clinically relevant,
previously intractable proteins.

Public health relevance
Narrative Lipid transport between membranes is a required for a multitude of fundamental cellular processes, including cell growth, phagocytosis, and exocytosis. This transport is primarily carried out by specialized lipid transport proteins that shuttle lipids across the aqueous environment of the cytosol. The goal of this proposal is to understand how lipid transfer proteins work and how their dysregulation is linked to neurological disease.